Fort Belknap Student, Faculty/Tribal Health Leader, and Nurse Training

PROJECT SUMMARY:
The Aaniiih Nakoda Tribes Native American Research Centers for Health (NARCH) XI student, tribal health
leader, faculty, and nurse training proposal will take a multi-pronged and innovative approach to developing a
pathway to higher education in nursing, public health, and STEM (science, technology, engineering, and
mathematics); research training; and mental health training. Through these efforts we will build Fort Belknap
research capacity; produce findings allowing for better data-informed decision-making; and meet health needs
prioritized by the Fort Belknap Aaniiih Nakoda Tribes. Our primary aims are to: (1) to develop and mentor
Aaniiih and Nakoda scholars through high school, undergraduate, graduate, and doctoral-level training in
nursing, public health, and STEM at Aaniiih Nakoda College (ANC), JHU, and other universities; (2) increase
research capacity of FBC nursing, behavioral/mental health, and public health leaders to engage in, design,
and advance culturally competent methods for research projects focused on reducing health disparities among
the Aaniiih and Nakoda Tribes; (3) to eliminate health disparities in mental/behavioral health through further
training of nurses that work on the rural and remote Fort Belknap Reservation by enhancing the scientific
knowledge of mental health care.
The NARCH XI grant will allow us to develop Aaniiih and Nakoda scholars as future leaders of our tribal health,
mental/behavioral health, and research efforts. We are developing a pathway for success in nursing, public
health, and STEM for Aaniiih and Nakoda scholars through training, education, and mentorship. These
activities will substantially increase our capacity to improve behavioral healthcare outcomes, especially for our
youth. Collectively, Aaniiih and Nakoda scholars and health leaders will participate in graduate coursework and
training that will lead to designing interventions targeting key health disparities and advancing research skills of
emerging Aaniiih and Nakoda scientists. Our adaptation of the existing Johns Hopkins School of Nursing
Psychiatric Mental Health Certificate Program for baccalaureate-level nurses will address our concern about
the lack of mental health professionals and can quickly be accessed by other Indigenous communities
nationally and globally.